University at Buffalo, SUNY Occupational Safety and Health Training Project

Project Summary
The University at Buffalo (UB), SUNY Occupational Safety and Health (OSH) Training Program prepares MS
degree graduates who go on to affect OSH practice in New York State and the surrounding region. Specific
objectives of the program include: 1) to provide a high-quality, comprehensive OSH education to our graduates,
and 2) to prepare graduates for the challenges faced by safety professionals through practical field experience
and professional development activities. MS level students from Industrial and Systems Engineering (ISE)
complete coursework on a breadth of OSH topics, including safety, industrial hygiene, toxicology, ergonomics,
and human-centered design, along with complementary courses in statistics, research methods, and engineering
management. Trainees also complete OSHA certification training to develop an understanding of regulatory
requirements. Specialization and practical experience is received through an internship and mentored capstone
field project experience, which prepares graduates to enter the OSH workforce. Throughout the program,
trainees participate in professional development activities and engage with safety professionals at local and
regional meetings. The program benefits from a strong collaboration between the ISE Department, the
Toxicology Research Center, and the Atlantic OSHA Training Center. Faculty members from each of these
groups work closely with the trainees in the courses, during the internship, and while advising their capstone
project. Since its inception in 2007, the program has been successful in producing safety professionals who have
continued on to careers with government agencies (including OSHA and NIOSH), industry, and academia. With
the current application, we propose to continue this success for a 4th cycle. Specific strengths of the UB program
include: the training of engineers in hazard recognition, injury prevention, and industrial hygiene, supporting
prevention through design initiatives; program faculty with a breadth of experience to mentor industrial and
applied research experiences in a variety of OSH areas; a strong connection with local industry to provide
internship and capstone projects; and the complement of coursework training, OSHA training, and field
experience to provide the background necessary to address today’s current OSH challenges. Improvement of
the program is supported by program evaluation. Program effectiveness is evaluated by course surveys and
grades, trainee exit surveys and interviews, and career placement and tracking of graduates. In addition,
feedback is solicited from an advisory committee of OSH professionals to ensure the program continues to
address employer needs. During the proposed project period, we aim to increase the enrollment of a diverse
group of trainees and have aligned our recruitment and retention efforts with the School of Engineering’s Diversity
Plan. Funding will allow for up to 6 trainees at the pre-doctoral (MS) level to be supported each year. The support
from NIOSH will enable the UB OSH Training Project to continue to have a positive influence on OSH practice
in New York and on the profession throughout the country.

Public health relevance
Project Narrative This application proposes a continuation of our occupational safety and health (OSH) training program that focuses on strengthening the pool of qualified OSH professionals in New York and the surrounding region. The program aims to meet industry needs by providing multidisciplinary training that includes coursework and practical experience to develop technical skills in safety, industrial hygiene, and ergonomics, along with professional skills in management, effective communication, and regulatory affairs.